From Training to Practice: Understanding the Integration of Evidence-Based Psychotherapies for Depression (INTEGRATE)

Background. Depression is a highly prevalent mental health disorder that carries a heavy disease burden and
is the 2nd leading risk factor for suicide among Veterans. VA has disseminated three effective psychotherapies
for depression to VA clinics but therapist use of these treatments is <12%. Surprisingly, no studies have
examined the provision of evidence-based psychotherapies for depression (D-EBPs) in VA and reasons
underlying infrequent delivery, leaving a critical gap in depression care delivery in VA. System factors are a
known driver of EBP use, and early signs from OMHSP's efforts and unique factors related to how depression
care is organized in VA warrant an empirical investigation. Significance. Low utilization of D-EBPs and the
lack of empirical evidence on barriers is a significant problem for several reasons. First, suicide prevention is a
top priority in VA and across the nation and untreated depression is a major risk factor for suicide. Second,
effectiveness of existing interventions that target provider-level barriers cannot be maximized without data
about system barriers. Increasing the reach of other EBPs (e.g., PTSD) has required intervention at all levels
(patient, provider, and system) and the same is undoubtably true for D-EBPs. Identifying and targeting system
factors and exploring therapist factors and conducting the first exploration of patient perceptions of D-EBPs will
bolster these early provider-focused interventions. Furthermore, this proposal is timely in that it comes on the
heels of OMHSP's shift from assessing anticipated barriers to D-EBP delivery during trainings to developing
partnerships to understand barriers experienced in the field. Finally, since this proposal is examining D-EBP
delivery in specialty mental health clinics where other mental health conditions are treated, findings have
implications of EBPs for those other conditions. Innovation/Impact. The proposed 3.5-year study will be the
first study to examine reasons for low utilization of depression EBPs by therapists in VA. Our mixed-methods
approach will yield a robust understanding of how the policies, resources and culture within specialty mental
health clinics contribute to low D-EBP use by therapists. Our aims are directly aligned with OMHSP's goal to
increase the implementation of clinical practice guideline-concordant care in VA mental health clinics. Our
proposed classification of all VA medical centers on system-level factors that are associated with D-EBP
delivery, strategic qualitative analysis, intervention mapping and stakeholder engagement provides invaluable
data to OMHSP and the field quickly. Aims. 1) Quantitatively examine the association between health system
factors and D-EBP delivery; 2) Qualitatively examine how contextual and system factors impact therapist
decisions around the provision of D-EBPs; 3) Develop a framework of intervention targets and potential
solutions to reduce barriers to D-EBP use; 4) Secondary/Exploratory Aims: a) Qualitatively explore how
therapist factors impact D-EBP use; b) Explore patients' perceptions of D-EBPs. Methodology. Using an
explanatory sequential mixed-method design, in Aim 1 (quantitative) we will abstract system-level and EBP
training data for FY21 Q3-FY22 Q2. Descriptive statistics of system-level factors and general linear mixed
model analysis will be used to characterize facilities and examine associations between system factors and
therapists' D-EBP use. This will enable us to quickly understand both the main correlates of D-EBP utilization
and variability of these factors across sites, provide critical data to our OMHSP partners and inform selection of
sites for Aim 2. Aim 2 and secondary aims (qualitative) will include interviews with therapists trained in the
three D-EBPs and mental health leaders from 10 VA medical centers (5 high and 5 low performers; N = 120-
150) and 20 patients to understand their perceptions of D-EBPs. Aim 3 will involve intervention mapping and
Delphi strategies to develop a framework for reducing system barriers to D-EBP delivery. Implementation.
Findings from our intervention framework development and strong partnership with OMHSP will maximize the
translation of study findings into practice.

Public health relevance
Effective psychotherapies for depression are available in VA but are underutilized by therapists working in specialty mental health clinics. Reasons for low use have not been empirically investigated. Findings from research on the implementation of evidence-based psychotherapies for other conditions such as PTSD cannot be fully generalized to depression because depression care is organized differently in VA. In this project, we use an explanatory sequential mixed-methods approach to examine contextual and system factors that impact delivery of evidence-based psychotherapies for depression as well as explore the impact of potential therapist- and patient-level factors. Findings will inform an intervention framework that will help our partners and stakeholders in the field to prioritize barriers on which to intervene and identify promising solutions.